Mechanisms of mRNA Recruitment into Stress Granules

ABSTRACT
The integrated stress response (ISR) is an evolutionarily conserved signaling network that is activated
in response to environmental stress and functions to support stress adaptation. A key part of the ISR is the
stalling of global translation while allowing for the preferential translation of stress response factors. Upon
stalling of global translation, mRNAs are incorporated into stress granules (SGs), which are cytoplasmic phase-
separated ribonucleoprotein granules. SG transcriptome studies have revealed that the efficiency with which
individual mRNAs are recruited to stress granules ranges from 1 to 95 percent, indicating a selectivity to mRNA
recruitment. However, little is known about the mechanisms by which mRNAs are selectively recruited to SGs.
Our lab has discovered a link between gene transcriptional state and SG incorporation, suggesting a model for
mRNA recruitment that favors the incorporation of newly transcribed and exported mRNAs rather than the
existing cytoplasmic mRNA population. This proposal seeks to investigate the mechanisms of mRNA
recruitment to SGs at a transcriptome-wide level, examining the role of transcription and nuclear export in SG
biogenesis along with assessing the contributions of newly transcribed versus existing cytoplasmic populations
of mRNAs. As stress granules have been implicated in multiple diseases, insights into how the mRNA
composition of SGs is determined could inform mechanisms of disease and potential therapeutics.

Public health relevance
PROJECT NARRATIVE Stress granules have been implicated in the pathobiology of neurogenerative diseases, cancer and viral infection though a mechanism of how stress granules contribute to disease remains under investigation. The research proposed here seeks to understand the biological function of stress granules and through that knowledge provide insight into mechanisms of disease and potential new therapeutic strategies.